Core 2: Molecular Profiling and Pathology

Project Summary/Abstract
The primary purpose of the Molecular Profiling and Pathology (MPP) Core is to provide the
investigators in this P01 with a centralized and coordinated resource for the analysis of human
lung cancer samples and xenografts and other mouse model tissues using morphologic and
high throughput molecular methods (histopathology, immunohistochemistry, in situ
hybridization, genomic analyses). The MPP Core functions within this P01 are grouped into four
logically connected Aims or activities. 1. Procurement of human lung cancer tissues for
validation studies. The Core will serve as the centralized resource for validation studies using
human lung cancer samples procured under several MKSCC IRB-approved protocols. 2.
Pathology review & analysis. The MPP core will provide expert histologic and cytologic
evaluation and classification of all human lung cancer specimens used in the P01, including
morphology-based assays (IHC, FISH). The MPP will also provide expert histopathologic review
of lung tumors in engineered mouse models as well as patient-derived xenografted human
tumors in immunodeficient mice. 3.Genotyping of human lung cancer tissues for validation
studies. The MPP Core is overseeing and curating the comprehensive genomic data generated
by prospective targeted sequencing of all lung cancers seen at MSKCC using the MSK-IMPACT
targeted hybrid capture/DNAseq assay and a complementary targeted RNAseq assay for
cancer fusions. This effort providing the extended mutational annotation of all MSKCC human
lung tumor resources that is critical for rational, well-designed validation studies biologically
relevant to specific leads arising from the Research Projects. The MPP Core also provides
NanoString-based targeted expression profiling of FFPE samples for validation studies. 4.
Coordination of validation studies using fully annotated human lung cancer tissues. The
activities described in Aims 1-3 are providing a rich collection of rigorously classified human
lung cancer tissues annotated for over 341 cancer-related genes including all key lung cancer
genes. Studies needed to validate the discoveries generated by the individual research projects
in human lung cancer tissues will be performed in or coordinated by Core personnel. Robust
platforms are established for DNA, RNA and protein analytes, with the specific validation
analyses being determined by the questions to be answered by the individual Research
Projects.

Public health relevance
Project Narrative The MPP core will serve a critical validation function, relating the findings of the Research Projects to human lung carcinomas and placing them in the context of key clinical, pathologic, mutational, and genomic parameters. Consistency of diagnostic criteria and technical platforms will ensure data comparability and data exchange between projects.